Enhancing Innate Immune Reconstitution Post Allogeneic HSCT.

Abstract
Allogeneic hematopoietic stem cell transplantation (allo-HSCT) is the preferred approach for the treatment of
patients with malignant diseases of the bone marrow (BM) and congenital BM failure syndromes. The efficacy
of allo-HSCT is dependent on the anti-tumor activity of the conditioning therapy and the donor graft. The
efficacy of allo-HSCT is dependent on the ability of donor bone marrow/stem cells to replace the host immune
system. However, it is clear that not all immune cells are generated from adult bone marrow cells. B1b
lymphocytes and Langerhans cells are generated from fetal cells and not reconstituted by donor bone marrow.
Additionally, our group and others have shown that innate lymphoid cells (ILC), which generate cytokines
similar to T lymphocytes but don’t express germ-line encoded receptors, are not completely reconstituted after
stem cell transplantation.
The mechanism for the absence of ILC2 cells in the GI tract post allo-HSCT is not clear as these cells routinely
are found in the bloodstream of patients and are reconstituted after autologous stem cell transplantation. Our
group has found in mice that fetal liver derived ILC2 precursor cells can reconstitute the GI tract indicating that
the niche can support ILC2 cells. This has led us to hypothesize that the inflammatory response found after
allo-HSCT from the GvH response limits the development of ILC2 cells.
ILC2 cells have significant plasticity, mediated by epigenetic changes in critical lineage-specific loci that leads
to the development of ex-ILC2 cells, which are functionally similar to ILC1 or ILC3 cells. Our group has found
that ILC1 cells, which generate IFN-γ, exacerbate GI tract GvHD. Furthermore, the pro-inflammatory cytokines,
IL-12 and IL-1β, which are increased post allo-HSCT especially in the presence of the GvH response, convert
ILC2 to ILC1 cells. Our group has found in ILC2 cells that H3K9me1/2 marks, which maintain gene
transcription of gata3, cmaf and rora, critical for ILC2 maintenance and function, are enhanced by inhibiting
lysine specific demethylases. The first specific aim focuses on enhancing the function of ILC2 cells in vivo to
treat GvHD by inhibiting Jumonji containing and lysine-specific demethylases.
Bronchiolitis obliterans syndrome (BOS) is a significant complication of allo-HSCT. T cells that generate IL-
17A, Th17 cells, are critical to the pathogenesis of BOS. One risk factor for BOS is an antecedent viral
infection of the lung, although the mechanism for this is not clear. Quite recently our group has found that viral
infection in the lung converts lung ILC2 cells to ILC3-like cells that generate IL-23 critical for the expansion of
Th17 cells. The second specific aim of this proposal focuses on the use of demethylases given with ILC2 cells
to prevent and/or treat post-viral BOS.
Completion of the goals of this project will greatly enhance our understanding of the mechanisms important for
the loss of ILC2 cells post-transplant, and provide new approaches to utilize ILCs to treat GvHD.

Public health relevance
Proposal Narrative Bone marrow transplantation is a preferred treatment for high-risk acute leukemia and other bone marrow diseases. Inflammation of the GI tract and lung, caused by donor white cells, is a significant cause of complications after transplant. We have found that a population of immune cells that block inflammation is lost after bone marrow transplantation. The goals of the current work are to better understand why these cells don’t develop after transplant. This should allow us to develop new methods to generate/maintain these cells to prevent transplant-associated inflammation.